Boston Health Equity & community-Aligned Learning Health System (Boston-HEALHS)

PROJECT SUMMARY - OVERALL
The Boston Health Equity & community-Aligned Learning Health System (Boston HEALHS) e-STAR proposal
will expand existing Learning Health System (LHS) capacity in a combined academic-safety net system to
create a robust and innovative program of research and training in LHS science. The integrated efforts of three
distinct cores will be managed by an experienced team of researchers and health system leaders, working
closely with and informed by a network of patients, community groups, clinicians, educators, and other local
stakeholders to ensure that the LHS research and training are community-engaged, patient-centered, and of
the highest quality, and that findings from LHS research are rapidly employed to improve care delivery.
The Administrative (Admin) Core will coordinate the overall activities of Boston HEALHS, creating an
organizational structure that provide efficient, responsive, and inclusive governance, with a particular focus on
engaging community, patient, and health system stakeholders in collaborative decision-making. The Admin
Core will oversee the recruitment and retention of LHS scientists participating in the training program, centering
diversity and equity at all stages, from job descriptions and initial outreach, through candidate selection, to
long-term professional development and retention. The Admin core will conduct a data-informed, community-
engaged process to identify priority topics for embedded LHS research, selecting those for which rapid-cycle
research results will have a meaningful impact on clinical operations and patient outcomes.
The Research Education Core (REC) will implement the LHS scientist recruitment, training, and retention. REC
leadership will fully develop the recruitment plans, drawing on multiple existing programs in our academic-
safety net partnership that promote equity. The LHS scientists matriculating in the program will be linked with
mentorship teams including both experienced researchers and health system leaders and will work with them
on detailed individual development plans that will be continuously updated during and beyond the training
period. The REC includes a large group of experts in the AHRQ-defined LHS competency domains who will
provide the LHS scientists with the tools to master these competencies, and the curriculum team will work with
scientists to identify didactic training opportunities in the PCORI methodology standards.
The Research and Data Analysis Core (RDAC) will connect LHS scientists participating in the training
program, as well as embedded LHS researchers across the institution, with linked data resources ideally suited
for rapid-cycle, clinically impactful research. The RDAC will employ community-engaged participatory research
principles to inform the selection of priority research topics, while simultaneously developing innovative
methods for the rigorous conduct of comparative effectiveness and patient-centered outcomes research in a
safety-net setting.

Public health relevance
PROJECT NARRATIVE The Boston Health Equity & community-Aligned Learning Health System (Boston HEALHS) e-STAR proposal builds upon existing Learning Health System resources and training programs to train scientists to tackle refractory problems of health disparities within a safety net system. The organizational infrastructure stimulated with the award will provide the scaffolding upon which to build a robust, sustainable Learning Health System that trains a new generation of diverse, methodologically rigorous, clinically embedded, and community- engaged scientists to design more effective, efficient, and equitable health systems.